Evaluating unique aspects of quiescent ovarian cancer cell biology for therapeutic targets

Most ovarian cancer (OvCa) patients develop fatal chemotherapy-resistant disease. Elucidating mechanisms
of chemoresistance in OvCa may identify therapeutic targets to prevent or treat relapsed OvCa. One
understudied mechanism of chemotherapy resistance in OvCa is quiescence. Quiescent cells are transiently
non-proliferating and thus refractory to standard therapies which target rapidly proliferating cells. The over-
arching hypothesis of this project is that hypothesis is that understanding the biology of quiescent
OvCa cancer cells will identify critical new therapeutic targets to improve patient outcomes. We have
used multiple novel approaches to identify and characterize the transcriptional signature of quiescent OvCa
cells. This work indicates that quiescent OvCa (qOvCa) cells have several unique characteristics including: (i)
a unique Quiescence Associated Secretory Phenotype (QuASP) which drives chemotherapy resistance in non-
quiescent cancer cells, and (ii) altered expression of select components of the ubiquitin-proteosome system
(UPS) including induction of UBL7. Indeed, our preliminary data indicate that induction of UBL7 is sufficient to
drive a quiescent cell phenotype, including the expression of the QuASP. Bio-informatic analysis of quiescent
OvCa cell RNAseq data identified the SRF/MRTF transcription pathway as being inversely correlated with the
OvCa quiescent signature. Consistent with this, a small molecule inhibitor of SRF/MRTF-mediated
transcription, CCG081, (i) induces UBL7, (ii) drives cells into a dense quiescent state, and (iii), indicating a
critical role for the UPS in quiescent cell viability, CCG081 sensitizes OvCa cells to proteasome inhibitors.
Based on these discoveries, we propose: SA 1: To characterize the OvCa QuASP. We hypothesize that,
characterizing the QuASP will identify critical biologic factors related to quiescence. We will identify QuASP
factors, validate the expression of QuASP factors in ovarian cancer and other cancer types, and use
knockdown and neutralizing antibodies to evaluate the function of these factors in quiescent OvCa cells.SA 2:
To determine the role of the UPS and UBL7 in quiescent cancer cells. We hypothesize that UPS changes
contribute to the quiescent cell state and are essential for quiescent cell viability. We will identify which
components of the UPS contribute to the quiescent phenotype, including expression of the QuASP, and
determine if the proteosome is essential to maintain quiescent OvCa cell viability. Finally, we will SA 3:
Evaluate the impact of targeting the proteosome quiescent cells in vivo. We hypothesize that the ability to
pharmacologically force these residual cells into a quiescent state and then eliminate these quiescent cells via
proteosome inhibition will increase cure rates. We will evaluate the therapeutic potential of combined CCG081
and FDA-approved proteosome inhibitors as consolidative therapy after chemotherapy to eradicate residual
quiescent cells. Impact: We will define the regulators of OvCa cell quiescence, providing therapeutic targets
eradiate to improve patient outcomes.

Public health relevance
Cancer cell quiescence is an understudied mechanism of chemotherapy resistance and drives poor outcomes for patients with ovarian cancer. We will study the unique biology of quiescent ovarian cancer cells to identify therapeutic vulnerabilities of quiescent cells. Based on our findings we will test novel therapeutic combinations to eradicate quiescent cells to overcome chemotherapy resistance and increase disease cure rates.